2023 Physical Science of Cancer GRC/GRS

Project Summary/Abstract
Despite the wide variety of genetic and molecular information available to characterize a patient's tumor, a
precise individual prediction of cancer progression is only possible to a limited extend. This suggests that vital
data about tumor progression are missing such as the physical and mechanical properties of cells and
surrounding tissue. Considering the complexity of cancer as a systemic disease recently high expectations
have been raised that an interdisciplinary approach by combining biology, chemistry, mathematics, engineering,
big data, and physics with biomedicine will lead to convergent oncology. Emergent phenomena which are not
directly triggered by a specific molecule can be only understood by a convergent approach. Partial support is
requested for the 3rd iteration of the "Physical Science of Cancer" Gordon Research Conference (GRC) to be
held from Feb.5-10, 2023, and the 2nd iteration of the “Physical Science of Cancer” Gordon Research Seminar
(GRS) to be held from Feb.4-5, 2023. These meetings will be held at the GRC-selected conference hotel (The
Grand Galvez) in Galveston, Texas. The conference is promised to provide a forum for the presentation and
discussion of recent advances and new ideas on multidisciplinary approaches and their success in
understanding fundamental cancer progression as well as in developing potential translational perspectives.
The long-term goal of this GRC is to facilitate the development and use of approaches to extend the range of
cancer targets that can be tackled successfully. These will be achieved with the following aims:
(1) Review advances and identify challenges in quantitative approaches in cancer.
(2) Train the next generation of scientists to quantitatively investigate the underlying physical mechanisms
that drive cancer (GRS) and facilitate diversity participation.
(3) Foster new collaborations with emphasis on using quantitative approaches to address challenges in
cancer.
Session topics have been selected on the basis of their potential impact on key scientific challenges of the field
and for their strength in transdisciplinary approaches. A focus on giving diverse voices, in background, stage
of career, and discipline will be central to our program. We will introduce inclusive mentorship as a primary
focus in order to better train and foster the next generation of multi-disciplinary cancer researchers. Poster
sessions will provide ample opportunities for engagement between investigators at all levels. We anticipate that
scientific interactions during this conference will impact cancer research in significant ways and result in
establishing productive multi-disciplinary research collaborations.
Collectively this conference will highlight the significant progress in the last four years, and catalyze the
development of new concepts and synergies that will aim to shape the future of Physical Sciences in Cancer
and allow us to holistically study phenomena. Ultimately, the dynamic interactions among these systems shape
the forces that drive tumor initiation, progression, metastatic spread, and disease recurrence. The application
of physics and mathematics foundations to the molecular, cellular, tissue, and organ level basis of cancer has
revealed fundamental changes during disease that are reflected across cancer types and stages. In this
conference we will hear from experts applying physical sciences to cancer to study disease phenomena across
scales and systems.

Public health relevance
Project Narrative The 2023 Physical Science of Cancer Gordon Research Conference (GRC) and the Physical Science of Cancer Seminar (GRS) have a primary aim of promoting productive scientific communication and collaboration between carefully- selected senior cancer biologist, clinicians and physical scientists alongside early career scientists in the Physics of Cancer field. Collectively we aim to highlight the recent significant progress in the field of Physics of Cancer, and catalyze the development of new concepts and synergies that will aim to shape the future of Physical Sciences in Cancer and examine how we can holistically study phenomena across biological scales.